Dissecting the role of amygdalo-striatal circuits in the regulation of stress and cocaine comorbidity in rats

SUMMARY/ABSTRACT
Generally, post traumatic stress disorder (PTSD) and substance use disorder (SUD) are examined seperately
in preclinical studies, although they can occur simultaneously in patients. Therefore, it is necessary to observe
these two disorders closely together to better understand the mechanisms that underlie this comorbidity and the
effects on the neurophysiology. One of the main problems in addiction is the high relapse rate when the patient
is exposed to environmental cues or other factors that can trigger memories associated with addiction. Presently,
one of the factors associated with a high relapse state is stress. Exposure to a stressful or traumatic events can
lead to the development of PTSD. Moreover, PTSD patients exhibit higher rates of SUD. Two important brain
structures involved in the development of these disorders are the basolateral amygdala (BLA) and the nucleus
accumbens ( NAc). The BLA concerns the development of fear memories and PTSD, while the NAc is part of
the reward circuitry and plays an important role in the progression of SUD. This NAc is sub-divided in two main
regions: the core and the shell. Studies have shown that the core drives cocaine-seeking behavior while the shell
modulates extinction, decreasing cocaine-seeking behavior. Importantly, the inhibition of BLA-NAc synapses
leads to a decrease in overall drug seeking behavior, but the effects of chronic stress on these synapses are still
unknown. The objective is to dissect the mechanism by which BLA modulates the NAc in a combined animal
model of PTSD and SUD. This will help to better understand how one disorder influences the other. The central
hypothesis is that chronic stress will induce neurophysiological changes to the BLA-NAc core and shell
synapses, which will correlate with increased cocaine-seeking behaviors. To address this, the team proposed
the following aims: Aim 1: Determine the effects of chronic stress on the neurophysiology of synapses of the
basolateral amygdala and nucleus accumbens prior to cocaine exposure. Aim 2: Determine the effects of optical
activation of BLA-NAc shell and core synapses independently on cocaine-seeking behavior in rats with chronic
stress prior to cocaine exposure. The overall goal is to understand how the chronic stress induced
neurophysiological changes in a rodent correlate with cocaine seeking-behavior changes prior to cocaine
exposure. The long-term goal is to understand the mechanisms and adaptations of the brain caused by a
traumatic event that leads to the development of PTSD and the susceptibility of acquiring SUD.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because substance abuse disorder has a high rate of comorbidity with anxiety disorders. This project seeks to elucidate the mechanism by which the basolateral amygdala modulates different subregions of the nucleus accumbens and how it alters drug-seeking behavior. In addition, results from this proposal may contribute to the identification of novel therapeutic approaches and provide the rationale for psychological interventions that could reduce drug seeking behavior.